Mitochondrial regulation and function in cancer and cardiovascular biology

Our laboratory is interested in the biology of p53 with a focus on its regulation of metabolism and how this can impact cancer and cardiovascular biology. To this end, we are studying Li-Fraumeni syndrome (LFS), an early onset cancer disorder caused by germline mutations in the TP53 gene, using both mouse models and translational studies involving LFS patients. Our investigations to date have yielded insights that may be useful for developing new strategies for preventing cancer and maintaining cardiovascular health. In collaboration with NCI intramural and extramural investigators, we are planning a clinical study to investigate the efficacy of metformin for chemoprevention in LFS patients. Bench to bedside investigations of LFS patients have revealed a novel mediator of chronic fatigue that we are now pursuing. We are also generating new p53 mutant mouse models to examine the role of p53 in the cardiovascular system including chemotherapy induced heart disease.